Incorporating Learning Effects into Medical Device Active Safety Surveillance Methods

Implantable medical devices have revolutionized contemporary cardiovascular care, and
are used in a wide spectrum of acute and chronic cardiovascular conditions. However, medical
device design fault or incorrect use may lead to significant risk of patient injury and represents
an important preventable public health risk in the United States. To help identify device-related
safety issues, a strategy of active, prospective, post-market safety surveillance has been
recommended by the FDA, and evaluated methodologically. This type of surveillance offers
significant advantages over traditional adverse event reporting strategies. However, all such
approaches are challenged by the need to incorporate learning effects into expectations
regarding safety. These learning impacts been repeatedly shown to have dramatic impacts on
outcomes during early device experience. Quantifying learning effects on the outcomes
associated with high-risk cardiovascular devices will improve our understanding of intrinsic
device performance, thereby identifying patient populations best treated with such devices while
simultaneously providing necessary feedback to device manufacturers to support iterative
improvement in device design. Separately, understanding the impacts of learning may identify
opportunities for targeted training as well as help to tease apart institutional and operator
characteristics that may accelerate the achievement of optimal outcomes in the use of the
specific cardiovascular device.
This proposal seeks to extend the previously validated, open-source, active, prospective
device safety surveillance tool, by developing and validating robust learning curve (LC)
detection and quantification algorithms, designed to simultaneously account for the effects at
the operator and institutional levels. We propose a “blinded” development strategy, in which
one team will generate robust synthetic clinical data simulator with LC impacts, and the other
team develops and applies LC detection and quantification algorithms, without knowledge of the
underlying relationships, determine performance and accuracy through sequential refinement
and validation steps. We propose to formally validate the optimized LC tools in real-world data
through re-analysis of previously published LC effects on transcatheter valves and vascular
closure devices using national cardiovascular registries. In addition, the LC tools will be
incorporated into two active, prospective device safety surveillance studies of novel implantable
cardiovascular devices using large clinical registries.

Public health relevance
This proposal seeks to understand the impact of institutional and physician learning on the safety of newly approved cardiovascular devices, and to use this knowledge to support and improve effective medical device safety surveillance. We propose a “blinded” strategy of separating simulated dataset generation from the learning effects detection and quantification algorithm development. Incorporating learning effects adjustment into a validated, prospective, near-real-time safety surveillance system, this research will improve public health by identifying poorer performing cardiovascular devices, and provide physicians, device manufacturers and public health officials with better information to optimize the use of medical devices, iteratively improve their design, and identify opportunities for enhanced training that will result in improved patient outcomes.